PRECHRONIC TOXICITY STUDY OF STYRENE

The objective of this project is to develop, evaluate, and report the methodology and results for generation and monitoring techniques necessary for conducting prechronic inhalation studies with styrene.